CORE--PROTEOMICS FACILITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Siteman Cancer Center (SCC) Proteomics Core provides multiplexed proteomic analysis to members of the SCC using the current and newly developed methods and reagents. These include two-dimensional differential gel electrophoresis with multiple fluorescent stains to quantify and detect functional groups, protein identification using tandem mass spectrometry (LC-MS/MS and MALDI-TOF/-TOF) and multidimensional liquid chromatography methods with differential stable isotope labeling. The SCC Proteomics Core is collaborating with the SCC Bioinformatics Core (Jeffrey Milbrandt, Core Director) and Multiplexed Gene Analysis Core (Mark Watson, Core Director) to build a laboratory information management system (LIMS) and a relational database to enable SCC investigators to access and query clinical, proteomics and mRNA array data through a single medical informatics portal.